Web-based Training Center

DESCRIPTION (provided by applicant) The primary aim is to facilitate the development and delivery of live, interactive HAZWOPER training through the use of internet-based Advanced Training Technologies (ATT). To this end, ATL has designed the ATL Web-based Training Center as a fully integrated portal that provides synchronous and asynchronous training from one access point for all students and instructors and is flexible enough to adapt to differing training and learning needs. Here hazardous materials workers, emergency responders, and skilled support personnel SSP can receive high quality health and safety training through the implementation of a wide variety of ATT including, virtual classroom (VC) hosting and instructor-led training; development of SCORM-conformant, self-paced courses including multimedia presentations and certification/refresher training; active-server page content development and hosting and learning management system (LMS) hosting; internal and external resource links and reference libraries; streaming content delivery, voice-over internet telephony (VOIP) and video conferencing; remote computer-assisted training, interactive pc/application/document sharing, and highly interactive HTML content using VBScripting and JavaScripting. This portal will be unique in its ability to integrate the functions of a traditional learning management system (i.e., asynchronous training), an all-IP (internet provider) web-based conferencing/training center (i.e., synchronous training), document server/resource center, and application service provider (ASP).